PHYSIOLOGICAL CHARACTERIZATION OF NIDDM

This project is designed to evaluate patients with noninsulin dependent diabetes, testing their responses at rest, during glucose ingestion and exercise. The hypothesis that will be tested is that these patients are classifiable into different subgroups based on their pathophysiological abnormalities.